Advancing Alzheimer’s family caregiving interventions and research capacity in Vietnam

ABSTRACT
A rapid demographic transition underway in low and middle-income countries (LMIC) will
substantially increase the number of older adults suffering from Alzheimer’s disease and related
dementias (ADRD) so that by 2030 more than 2/3 of all persons suffering from ADRD worldwide
will reside in LMIC. Consequently, there is growing recognition in Vietnam and other LMIC that
ADRD poses a major public health issue and the importance developing scientific evidence and
research capacity to meet this challenge, including developing effective community-based
support programs for family caregivers of persons with Alzheimer’s disease. Building on an
established cross-national partnership between investigators in Vietnam and two HIC (US and
Australia), the overall goals of this project are to test the efficacy of a community-based program
to support Alzheimer’s family caregivers in Vietnam and to strengthen research capacity through
development of a national Vietnam ADRD research network. To achieve these goals, we will
build directly on the accomplishments of our planning grant. We now have in place a robust and
effective collaborative relationship between investigators in HIC (US and Australia), the Vietnam
National Geriatric Hospital (NGH), and the Vietnam Ministry of Health (MOH). Our research
team has culturally adapted, implemented and tested the feasibility and preliminary efficacy of a
community-based family ADRD caregiver intervention model (REACH VN) in a pilot cluster RCT
of 60 family caregivers. Preliminary results of our pilot cluster RCT show strong evidence of
both feasibility and preliminary efficacy. We now propose to test the efficacy of the REACH VN
in a larger cluster RCT embedded in the community using a Stage III clinical trial design coupled
with a formative evaluation using the RE-AIM framework to inform future implementation. We
will also enhance ADRD research capacity more broadly in Vietnam by establishing a national
network of researchers and creating a linked pilot grant program to provide mentoring and
funding to meritorious scientists conducting ADRD research on family caregiving and other
issues of high relevance to policy makers. Specific goals of this project are to 1) test the efficacy
of REACH VN in Vietnam in cluster randomized controlled trial of 32 clusters (350 families), 2)
identify key barriers and facilitators of REACH VN implementation in a community setting
through a formative evaluation conducted in parallel with the cluster RCT, and 3) strengthen and
build Vietnam national capacity in caregiving and other ADRD research through the creation of
a network of researchers and a program of mentoring and pilot support.

Public health relevance
PROJECT NARRATIVE Worldwide, a large majority of persons with Alzheimer’s disease and related dementias (ADRD) reside Vietnam and other low and middle-income countries (LMIC) compared with high income countries, a trend that will be magnified in decades to come. ADRD are among the most disabling and costly neurodegenerative brain diseases and is a growing public health concern in Vietnam, one of the most rapidly aging countries in Asia. To address the public health challenge of ADRD in Vietnam, the goals of this R-01 application are to test a culturally adapted, community-based family caregiver intervention and to strengthen ADRD research capacity in Vietnam through the development of national research network and an embedded mentored pilot grant program for Vietnamese scientists. The project will be conducted through a partnership of investigators in Vietnam, the US, and Australia.